PHASE I STUDY OF TAXOL IN REFRACTORY LEUKEMIA IN CHILDREN

To identify the highest and most effective dose of Taxol in treating recurrent leukemia which is not effectively being controlled by standard treatment.